Perceptual implications of cochlear implant electrode-neuron interfaces

Project Summary/Abstract
Cochlear implants are highly successful neural prostheses that enhance or restore audition to severely
hearing-impaired adults and children. Sound from the environment is converted into electrical pulses and
conveyed to the auditory nerve by an array of electrodes. The cochlear implant provides important spectral and
temporal information to the listener. However, speech perception performance varies considerably among
cochlear implant listeners, particularly in noisy environments and for complex stimuli. This variability exists
even for children who receive their cochlear implants early in development (<2 years old).
Recent evidence suggests that children have a higher density of healthy auditory neurons, which are
the target of stimulation through an implant. There is also a critical period for auditory developmental plasticity.
The interaction of these factors and the chronic electrical stimulation of a cochlear implant are not well
understood, especially for early-implanted children. Despite these known differences between adults and the
immature auditory systems of children, cochlear implant research has focused on adults. In adults, the most
promising methods for optimizing programming strategies include focusing the electrical field emitted by each
electrode to stimulate a more restricted population of neurons and deactivating less effective electrodes. Very
few attempts have been made to optimize programming strategies specifically for children, and recent
evidence suggests children would benefit more than adults from focused stimulation. Moreover, when new
programming strategies are implemented, there is limited data about the timecourse needed to assess their
effectiveness.
Three aims are proposed: 1) Determine the underlying mechanisms for spectral resolution in children
and adults with cochlear implants by comparing peripheral physiological and behavioral tuning across the
lifespan; 2) Quantify short-term changes (over hours) in speech perception in children and adults when using
optimized programming strategies with selective channel deactivation with and without focused stimulation;
and 3) Quantify long-term changes (over weeks) in speech perception in children and adults using the same
optimized strategies as in Aim 2.
The results of the proposed studies are expected to advance our understanding of how the implanted
auditory system develops, how cochlear implants should be programmed to best deliver spectrally challenging
signals, and the timecourse of acclimatization to changes in programming strategies. These findings could
guide clinical decision making about when to make programming adjustments, what types of adjustments to
make, and how long patients need to reach peak performance following adjustments. The results from these
studies could ultimately lead to improved functional outcomes for children and adults with cochlear implants.

Public health relevance
Project narrative Despite the success of cochlear implants, devices surgically placed in the inner ears of patients with severe hearing loss, there remains substantial variability in the overall speech perception outcomes for the children and adults who receive them. The main goals of this project are: i) to improve our understanding of how cochlear implants affect the developing auditory system, ii) apply that knowledge to test new methods for programming children and adults, and iii) to study how long it takes listeners to adapt to new cochlear implant programs over the short- and long-term. The results will improve our understanding of how the deafened auditory system develops with cochlear implant stimulation and advance clinical practice to improve hearing outcomes in cochlear implant listeners.